Bio-RaPID: Biomarkers and Rates of Progression In Dementia.

PROJECT SUMMARY
Patients with rapidly progressive dementia (RPD) experience accelerated declines in cognition resulting in
dementia within 1 year or complete incapacitation within 2 years of symptom onset. Although the medical
literature has long emphasized the contributions of Creutzfeldt-Jakob disease to RPD, rapidly progressive forms
of Alzheimer disease and AD-related dementias (rpAD/ADRD) account for most cases of RPD in older
individuals. The rapid rate of decline in patients with rpAD/ADRD presents a great clinical challenge for the
assessing clinician but also a unique opportunity to study the biological factors that underlie this extreme
endophenotype across a shortened symptomatic period. The Biomarkers and Rates of Progression in Dementia
(Bio-RaPID) study will capitalize on this opportunity by enrolling and evaluating 120 patients with rpAD/ADRD.
Recruitment will be supported by a 9-site referral network engaging 7 Alzheimer Disease Research Centers with
expertise in recruitment of underrepresented groups. Structured clinical evaluations will be conducted at
baseline, 12-, and 24-months at Mayo Clinic Jacksonville (FL) or Rochester (MN). Interval telemedicine
assessments with remote blood collection at 3- and 6-months will minimize participant burden while enabling
serial measures of cognitive function and blood-based biomarkers. In this way, Bio-RaPID will combine clinical
expertise, validated diagnostic approaches, long-read whole genome sequencing, and gold-standard in vivo
measures of amyloid (A: CSF ptau181/Aβ42), tau (T: flortaucipir PET), neurodegeneration (N: MRI),
cerebrovascular disease (V: MRI), pathologic aggregates of α-synuclein (CSF seed amplification assay), and
biofluid biomarkers of neuroinflammation to determine the patient- and disease-specific factors that contribute to
rpAD/ADRD. Use of ADRC protocols and coordination with ADRC Cores will enable comparison with existing
patients with typical AD/ADRD and broad sharing of Bio-RaPID data. This “whole patient, whole brain” approach
will inform the influence of patient-specific factors on rpAD/ADRD susceptibility, including age, sex, medical
history, structural and social determinants of health, genetic variants, and ATN(V) and α-synuclein pathology
(Aim 1); and the contributions of disease-specific factors to disease progression, including burden and topology
of neuropathology and the mediating effects of neuroinflammation (Aim 2). Finally, Bio-RaPID will leverage
unbiased proteomic analyses in CSF from an independent cohort of patients with autopsy-confirmed rapid and
typical AD/ADRD (n=120, each) to validate findings from Aim 1 and 2 and identify cellular/protein pathways that
are uniquely expressed or altered in rpAD/ADRD (Aim 3). Bio-RaPID aims will inform the cumulative contributions
of demographics, concurrent health issues, structural and social determinants of health, genetics, biofluid
biomarkers, and ATN(V) neuropathology to cognitive decline and synaptic dysfunction in rpAD/ADRD. In turn,
these findings will be extended to identify biomarkers and novel treatment targets with the potential to arrest or
slow pathologic progression in patients with rapid and typical progressive AD/ADRD.

Public health relevance
PROJECT NARRATIVE Rapid progressive forms of Alzheimer disease (AD) and AD-related dementias (ADRD) account for most cases of rapid progressive dementia in older patients, yet the factors that contribute to these extreme clinical phenotypes are unknown. The Biomarkers and Rates of Progression in Dementia (Bio-RaPID) study will enroll, evaluate, genetically characterize, and prospectively apply multimodal (imaging and biofluid) biomarkers to decipher the patient- and disease-specific factors that associate with rapid progressive AD/ADRD; these data will be compared with findings in patients with typical progressive AD/ADRD enrolled in Alzheimer Disease Research Center studies. Findings in prospectively evaluated patients will be validated through expansive proteomic analyses in cerebrospinal fluid from an independent cohort of patients with autopsy-confirmed rapid progressive AD/ADRD and results extended to identify biomarkers and disease-modifying targets for AD/ADRD.